Perceived Discrimination, Intersection of Identities, and Health Risk Behaviors in Black Adolescents

Discrimination is nearly pervasive, with Black youth averaging five experiences of racial discrimination
daily. Discrimination is a determinant of health for historically marginalized populations, and linked to
decreased psychological, physical, and emotional functioning, negative affective states, and increased
health risk behaviors such as substance use and maladaptive eating. Black youth also have been identified
as particularly disadvantaged because of misdiagnosis and overdiagnosis of certain psychiatric disorders,
underdiagnosis of others, and limited access to mental health treatment. With the additional stressor of
experiencing discrimination and mental health care inequities, Black youth are at increased risk for
engaging in health risk behaviors. Unfortunately, most screening tools and interventions fail to account for
the lived experiences of Black youth and are based on and provided primarily for White youth. The
proposed project seeks to develop, refine, and test a culturally appropriate theoretical model of the
contexts (social, emotional) in which discrimination and health risk behaviors occur among Black youth
while considering intersectionality. Specific Aim 1 will explore the contexts (social, emotional) in which
discrimination and health risk behaviors occur in Black youth while considering intersectionality and
develop an ecological assessment protocol. To test this aim, up to 30 Black adolescents aged 14-17 years
with substance use and/or maladaptive eating behaviors will be recruited to complete focus groups and a
survey. Drawing on qualitative data, an ecological momentary assessments protocol will be developed and
refined. Specific Aim 2 will explore whether the ecological momentary assessment protocol accurately
captures the contexts in which discrimination and health risk behaviors occur in Black youth. To test this
aim, up to 30 Black adolescents aged 14-17 years with substance use and/or maladaptive eating behaviors
will be recruited to complete focus groups and a survey. Specific Aim 3 will evaluate the feasibility and
acceptability of the ecological momentary protocol with a subset of 10 Black youth. This study fills a
fundamental gap by being one of the first to refine and test a culturally appropriate theoretical model of
health risk behaviors in Black youth and one of the first to consider intersectionality. Findings from this
study will provide specific insight into how to adapt screening tools and interventions for health risk
behaviors in Black youth to be more culturally appropriate.